Neural circuit dynamics of spatial reward memory

Project Summary / Abstract
Our strongest memories often stem from our most rewarding experiences, allowing us to learn what features of
experience predict reward and to use these predictions in the future. The ability to remember rewarding spatial
locations, such as food sources, is crucial for survival. In humans, reward memory can become dysfunctional in
memory disorders and mental illnesses like drug addiction, highlighting the need to understand how the brain
amplifies information associated with rewards. The hippocampus and medial entorhinal cortex (MEC) comprise
a potential neural circuit for this amplification process. Neurons within these regions construct and update a
neural map of spatial experience, notably "overrepresenting" reward locations within the neural activity. However,
it remains unclear exactly what aspects of the rewarding experience the overrepresentation encodes and how
this information is learned. The goal of this proposal is to understand the neural dynamics of how the reward
overrepresentation develops in both the hippocampus and MEC and how this process is synchronized within the
hippocampal-MEC circuit. To achieve this goal, the proposal combines powerful neural recordings technologies
across rodent species, using innovative behavioral tasks that disentangle the reward itself from sensory stimuli,
movement dynamics, and the cognitive demand of remembering a specific location which predicts reward. Aim
1 (K99) will use calcium imaging to determine whether changing cognitive demands shape the hippocampal
reward overrepresentation over learning. Aim 2 (K99/R00) will use high-density electrophysiology to disentangle
reward and cognitive demand in the MEC code, tightly controlling for motor correlates around goals. Aim 3 (R00,
pilot K99) will combine simultaneous recordings in the hippocampus and MEC with inactivation of each region
to dissect their reciprocal contributions to spatial reward memory and decision-making. This work will build on
the candidate’s extensive expertise in electrophysiology and behavior by providing training in three key scientific
domains, under lead mentor Lisa Giocomo: (1) computational modeling and statistical analysis with the guidance
of co-mentor Scott Linderman, to illuminate how neural coding properties change in different task states; (2)
calcium imaging with advisor Jun Ding, to solidify a toolkit to monitor the circuit dynamics underlying flexible
coding; and (3) hippocampal and cortical population dynamics with advisors William Newsome and André
Fenton, to understand how population activity is structured and coordinated across regions at moments of
decision-making. The training plan will build professional skills in inclusive mentorship, lab management, and
scientific communication to propel a transition to independence. Stanford University offers a collaborative,
interdisciplinary, and supportive environment to pursue cutting-edge science and launch an independent career.
The proposed work will provide key insights into how and when spatial reward information is amplified in the
brain, building a foundation for the candidate’s career goal: to investigate how neural circuits flexibly shape the
information stored in memory according to behavioral demands.

Public health relevance
Project Narrative Rewarding experiences must be remembered clearly to guide healthy learning, but this memory process can be disrupted in disorders such as dementia and drug addiction. To address our limited understanding of how the brain amplifies the events surrounding reward in memory, this research will leverage large-scale recording technologies to uncover the neural dynamics involved in forming spatial reward memories in two key brain regions, the hippocampus and entorhinal cortex. By investigating what aspects of the rewarding experience are stored and how they are stored, this work will enhance our knowledge of normal memory function and provide insight into neural processes that could deteriorate in mental disorders.